Tissue Chip Data to the Microphysiology Systems Database (MPS-Db) Supplement to A Microphysiological System for Kidney Disease Modeling and Drug Efficacy Testing

ABSTRACT In response to the critical need for in vitro models that recapitulate human kidney diseases, we have developed an in vitro kidney chip model that recapitulates critical aspects of kidney physiology, can assess the mechanisms and response to injury, and test reparative mechanisms, all of which can substantially enhance therapeutic discovery and evaluation. We have demonstrated success in delineating novel molecular drivers of both disease processes and drug induced-nephrotoxicity. The goal of the parent application is to advance our “kidney on a chip” MPS in order to model important human kidney diseases and promote identification of safe and effective treatments. Datasets generated from MPS disease models will be submitted to the Microphysiology Systems Database (MPS-Db); these data will include components including: MPS flow and chip architecture, cell growth conditions and parameters, iPSC differentiation conditions, cell characteristics (transcriptional data, bulk and single cell RNA sequencing, genotyping, morphology, cytokine production/response), and stress and therapeutic response to small molecule agents. We believe that publicly accessible data generated from tissue chips will facilitate acceptance of MPS technology in both academic and industrial settings, particularly when data can be evaluated in parallel with preclinical and clinical databases. This proposal will enable submission of existing data from MPS models of disease states that occur in both adults and children, and are not represented presently in the MPS-Db. Furthermore, we will develop protocols and templates to incorporate data submission into our experimental workflow to ensure timely submission of future data.

Public health relevance
NARRATIVE In response to the critical need for in vitro models that replicate human kidney diseases, we have developed an in vitro kidney chip model that has successfully delineated novel molecular drivers of disease processes. Our human kidney MPS recapitulate the architecture and function of normal kidney physiology and pathophysiology in vivo. The datasets generated from these MPS disease models will be submitted to the Microphysiology Systems Database (MPS-Db). Furthermore, we will develop protocols and templates to incorporate data submission into our experimental workflow to ensure timely submission of future data.